Project 2: Coordinate regulation of liver energy balance by PPARalpha/SRC-1 and FXR/SRC-2

Project 2 -­ Project Summary

The primary goal of this project is to elucidate the roles of the nuclear receptors PPARα and FXR, and the
coregulators SRC-­1 and SRC-­2, in the overall control of energy balance in the liver. PPARα is activated in the
fasted state, promoting fatty acid oxidation and gluconeogenesis. FXR is activated in the fed state and represses
gluconeogenesis. Transcriptional functions of PPARα and FXR are mediated by the SRC family of coactivators,
and the members of this Program Project team have shown that SRC-­1 and SRC-­2 are also central regulators
of liver energy balance. SRC-­2 promotes hepatic fed state functions, including glucose uptake and lipid
absorption, and SRC-­2 activity is inhibited in the fasted state. In contrast, SRC-­1 is induced by fasting and is
essential for activation of gluconeogenesis in the fasted state. We have recently shown that PPARα and FXR
coordinately regulate another fundamental nutrient response in the liver, autophagy, via mutually antagonistic
effects of induction and repression. Our preliminary results identify the hepatic secretome as another, quite
unexpected potential target for complementary control of liver energy balance. Secretion is a very energy
intensive function of the liver, and we have evidence that FXR activates the hepatic secretome, while PPARα
represses it. Based on these results, our overall hypothesis is that PPARα, in concert with SRC-­1, and FXR, in
concert with SRC-­2, regulate broad pathways of energy utilization and production in the liver to maintain energy
balance. We propose 3 aims to critically test this hypothesis and explore the mechanistic basis for these effects.
1. Complete the genome wide cistromic, transcriptomic, proteomic and metabolomic profiling of the roles of
PPARα and FXR in the fed and fasted liver. 2. Define the role of SRC-­1, SRC-­2 and NCoR in the opposing
effects of PPARα and FXR in vivo. 3. Define the structural and functional basis for the conversion of FXR/RXR
heterodimers from ligand dependent transcriptional activators on IR-­1 sites to ligand dependent transcriptional
repressors on DR-­1 sites, and define the coregulators associated with both.

Public health relevance
Project 2 - Project Narrative This proposed project will provide a much more complete understanding of the therapeutic effects of two distinct approved drugs. The nuclear receptor PPARα is the target of the fibrate drugs that are used to treat elevated serum lipids; FXR is the target of ocaliva, which was recently approved to treat cholestatic liver disease but has also shown beneficial effects in the metabolic syndrome. This project will provide important new insights into the mechanisms of action of fibrates and ocaliva, which will lead to new strategies to augment their beneficial impacts while minimizing potential deleterious effects.